Core A - Administrative Core

Project Summary
The intent of this SPORE award is to create a flexible research program that responds rapidly to
new advances in basic science by implementing changes in patient care. This challenge can
only be undertaken if its governing body has the ability and authority to continuously monitor
research plans and progress and make changes when necessary to ensure that research
conducted by the SPORE maintains its translational focus. In addition, this program must be
able to draw upon the resources of a large research infrastructure in order to achieve its
ambitious goals. The purpose of the Administration, Evaluation and Planning Core is to
coordinate the varied components of the DF/HCC GI SPORE necessary to provide oversight
and leadership of the scientific, administrative and fiscal aspects of the SPORE.
The Administration Core's specific aims are:
Aim 1: Select projects, monitor research progress, and plan for the future
Aim 2: Foster collaborative research within the SPORE and between SPOREs
Aim 3: Integrate the GI Cancer SPORE into the structure of the DF/HCC
Aim 4: Provide necessary resources and fiscal oversight
Aim 5: Promote rapid dissemination of significant research findings and facilitate resource
exchange between the DF/HCC SPORE and other institutions

Public health relevance
Project Narrative The purpose of the Administration, Evaluation and Planning Core is to coordinate the varied components of the DF/HCC GI SPORE necessary to provide oversight and leadership of the scientific, administrative and fiscal aspects of the SPORE.